Understanding regulation of pediatric regenerative myogenesis and its implication for muscle disease

ABSTRACT
The maintenance of healthy skeletal muscle and its regeneration following acute injury involves precise
regulation of the resident stem cell response by the surrounding muscle niche. Pediatric muscles respond
quickly and are more proficient at regenerating from injury. The decline in regenerative capacity of geriatric
muscle is widely studied, where the muscle niche is recognized to be a key contributor in the decline of the
regenerative capacity of the muscle stem cells. However, the factors that support efficient regenerative
capacity of pediatric muscle are less understood. The limited work in this area has focused on ex vivo
examination of the intrinsic myogenic capacity of muscle stem cells but fails to capture the role of the muscle
niche in driving pediatric muscle regeneration. An understanding of this is required as multiple degenerative
muscle diseases, such as DMD, manifest from early childhood, where therapies that can maintain or further
enhance pediatric muscle regenerative capacity can ameliorate the impact of this disease. The work proposed
here aims to address this knowledge gap by building on our preliminary studies implicating the interplay of
immune and stromal factors in the muscle niche for efficient regenerative myogenesis of pediatric muscle (Aim
1) and identify how these interactions are impaired in dystrophic that attenuates regenerative myogenesis and
how targeting this holds therapeutic potential (Aim 2). We will make use of a combination of single-cell and
spatial RNA transcriptomic analyses together with various DMD mouse models and patient samples to
examine this process and validate our findings. Through use of these complimentary approaches the work
here will provide basic insights into the regulation of healthy pediatric regenerative myogenesis with broad
applicability to DMD and other pediatric onset degenerative muscle wasting diseases.

Public health relevance
NARRATIVE Skeletal muscle regeneration requires coordinated actions of muscle stem cells and a multitude of muscle- resident cell types that regulate the stem cell niche. We have identified immune and stromal components of the muscle niche differentially modulate the efficiency of the muscle stem cell response in pediatric and adult muscle, which is altered in the context of degenerative pediatric muscle diseases. The work in this proposal will decipher how the muscle niche promotes efficient regeneration and how alteration in this in pediatric-onset degenerative muscle wasting diseases, such as Duchenne Muscular Dystrophy, contributes to disease progression and severity.